The road to recovery: An assessment of patient-reported quality of life among cancer survivors in Malawi.

PROJECT SUMMARY/ABSTRACT: Increasing efforts to improve early detection, diagnosis, and treatment of cancers in low resourced countries have led to modest improvements in cancer survival and given rise to an expanding population of cancer survivors. However, there is a gap in the understanding of cancer survivorship in low resourced countries. The goal of this proposal is to measure health-related quality of life (HRQoL) for cancer survivors with Kaposi sarcoma (KS) and lymphoma across the continuum of cancer care in Malawi. In line with NCI's definition of a cancer survivor, our survivor population includes any individual diagnosed with cancer from the time of diagnosis through the balance of life. We hypothesize that: a) KS and lymphoma survivors will have differences in mental health and physical function domains of HRQoL before (pre-), during (mid-), and up to 1 year after (post-) cancer-directed treatment; and b) there is no difference in post-treatment HRQoL among short-term (< 1 year since treatment completion), medium-term (?1-5 years since treatment completion) or long-term (> 5 year since treatment completion) survivors.

Public health relevance
PROJECT NARRATIVE There is evidence from high resource countries that cancer survivors experience poor HRQoL due to effects of cancer or its treatment. To understand challenges faced by cancer survivors and identify strategies or opportunities to develop locally relevant patient-centered interventions to improve survivorship outcomes, it is critical to elucidate patient-reported HRQoL across the cancer control continuum and among diverse cancer types. This study will measure health-related quality of life (HRQoL) for cancer survivors with Kaposi sarcoma (KS) and lymphoma across the continuum of cancer care in Malawi.